A role for DUSP5 in aging and obesity

PROJECT SUMMARY
Aging is characterized by chronic, low-grade inflammation that has been termed “Inflammaging.” Similar to aging,
obesity is linked to chronic inflammation and older obese adults are at higher risk for developing insulin resistance
and ultimately diabetes compared to their lean and aged counterparts. Adipose tissue links inflammaging and
obesity to the development of insulin resistance. The mitogen-activated protein kinase (MAPK) family can
promote adipocyte insulin resistance and promote/exacerbate adipocyte inflammation. For instance,
phosphorylation of the MAPK, extracellular signal-regulated protein kinase 1/2 (ERK1/2), inhibits insulin signaling
and induces inflammatory gene expression. However, it is unclear how MAPKs are deactivated in response to
adipose tissue inflammation and if MAPK deactivation is critical to compensate and protect against aging-
induced insulin resistance in lean vs obese populations. Deactivation of MAPKs is critical for homeostasis in
order to maintain adipose tissue function, whereas loss of deactivation potentially amplifies MAPK pro-
inflammatory signals that drives metabolic disease progression. Thus, there is a critical need to understand the
molecular underpinnings for MAPK deactivation that initiate and fuel inflammaging and obesity in order to identify
potential therapeutic targets to treat the progression of subclinical aging before permanent phenotypes like
diabetes manifest. This project tests the hypothesis that that dual-specificity phosphatase 5 (DUSP5) is a critical
deactivator of nuclear ERK1/2 signaling that serves as a feedback inhibitor to limit Inflammaging-induced insulin
resistance in adipose tissue, particularly when linked to obesity. Two aims have been devloped in this proposal
to test this postulate. Aim 1, will test the hypothesis that DUSP5 knockout mice have aggravated inflammation,
insulin resistance and ERK1/2 activation in aged mice vs. lean counterparts. Aim 2, will test the hypothesis that
obesity exacerbates aging-induced inflammation and insulin resistance in DUSP5 knockout mice. This proposal
will highlight an emerging role for phosphatases, particularly DUSP5, in adipocyte biology and provide new
insights into the control of adipose tissue inflammaging and obesity linked insulin resistance.

Public health relevance
PROJECT NARRATIVE Aging and obesity are major public health concerns that lead to diabetes and cardiovascular diseases. Evidence shows that chronic, low-grade inflammation in older adults, particularly obese individuals, contributes to insulin resistance and thus diabetes, yet the molecular pathways that link inflammatory signaling remain unclear. This proposal will investigate how a dual-specificity phosphatase (DUSP), DUSP5, works to regulate inflammatory signals to reduce insulin resistance in response to aging and obesity; and thus could highlight a novel therapeutic target for metabolic diseases. .